An investigation of the long-term impact of in-utero exposure to mild chronic hypertension and antihypertensive therapy on childhood subclinical cardiovascular risk factors

Abstract
Children with in-utero exposure to hypertensive disorders of pregnancy (HDP; gestational hypertension, chronic
hypertension, preeclampsia, and superimposed preeclampsia) have an increased risk for hypertension and
cardiovascular disease (CVD). Our preliminary data indicate that administering first-line antihypertensives
during pregnancy improves neonatal outcomes. However, the long-term impact of in-utero exposure to
antihypertensive treatment on childhood subclinical CVD risk factors (i.e., high oxidative stress, inflammation,
and arterial stiffness) is unknown. Further, it has not been established whether environmental exposures
influence the association of in-utero exposure to HDP on childhood subclinical CVD. Assessing subclinical
CVD in childhood is particularly important because longitudinal research shows that poor
cardiovascular health in childhood is associated with a higher incidence of hypertension,
atherosclerosis, and other cardiovascular events in later life. Thus, the objectives of this study are to 1)
Investigate whether in-utero exposure to antihypertensive treatment (compared to no treatment) is associated
with improved childhood (ages 5–10 years) subclinical CVD, and 2) Examine whether neighborhood deprivation
(i.e., a composite measure of environmental exposures) influences the association between in-utero exposure
to HDP and offspring subclinical CVD. The central hypothesis is that in-utero exposure to antihypertensive
treatment is associated with improved subclinical CVD among children born to mothers with HDP. We also posit
that neighborhood deprivation significantly influences the association between in-utero exposure to HDP and
offspring subclinical CVD. Completion of the research aims in this proposal will inform the development
of an intervention to improve vascular outcomes among children born to mothers with HDP. This research plan
will be augmented by intensive mentoring from a multidisciplinary team of experts, didactic coursework, and
formal training at the University of Alabama at Birmingham and the National Heart, Lung, and Blood Institute.
The training plan was crafted to ensure that Dr. Martin achieves her specified career development goals, which
are to 1) Develop advanced skills to assess subclinical cardiovascular risk factors in children and gain a deep
understanding of the intergenerational transmission of CVD, 2) Develop expertise in the assessment of social
determinants of health and environmental exposures, 3) Develop a comprehensive knowledge of intervention
approaches and statistical analysis for clinical research in maternal-fetal-child health; and 4) Refine grant writing
skills for future grant mechanisms. Completion of the training aims in this proposal will transform clinical
care by providing new insight regarding the long-term impact of in-utero exposure to antihypertensive treatment
and will uniquely position Dr. Martin for a career that allows her to make a significant contribution to slowing the
progression of CVD for high-risk children born to mothers with HDP and other exposures.

Public health relevance
NARRATIVE The proposed study seeks to 1) Investigate whether in-utero exposure to antihypertensive treatment is associated with offspring subclinical cardiovascular disease risk factors (i.e., oxidative stress, inflammation, and arterial stiffness) and 2) Examine whether neighborhood deprivation (i.e., a composite measure of environmental exposures) influences the association of in-utero exposure to hypertensive disorders of pregnancy on offspring vascular outcomes. Successful completion of this study will enhance the candidate’s career development and inform the planning of a future intervention to improve vascular outcomes among children born to mothers with hypertensive disorders of pregnancy. This project leverages an experienced multi-disciplinary mentorship team and is a single-site ancillary study within a larger follow-up study of a chronic hypertension treatment trial funded by the National Heart, Lung, and Blood Institute (NCT02299414).